Dysregulated mechanosignaling in dilated cardiomyopathy caused by defective Filamin C

PROJECT SUMMARY / ABSTRACT
A common and deadly form of familial heart disease is dilated cardiomyopathy (DCM), which is typically
characterized by adverse cellular and ventricular remodeling and systolic dysfunction. DCM is often associated
with loss-of-function mutations in genes encoding sarcomeric or cytoskeletal proteins. Mechanotransmission and
mechanosignaling in cardiomyocytes (CMs) rely on these protein networks, particularly in the costamere, which
provides a direct mechanical link between the extracellular matrix (ECM) and the Z-disk of the sarcomere. The
costamere may therefore regulate both ‘inside-out’ mechanotransmission (transmitting sarcomere-born forces
out to the ECM) and ‘outside-in’ mechanosignaling (transmitting/transducing extracellular mechanical signals
into the CM)—the dysfunction of either of which may be central to DCM progression. My overall hypothesis is
that the costamere and cortical cytoskeleton of cardiomyocytes provide key mechanosensitive protein networks
that regulate mechanical signalling pathways initiated by intracellular and extracellular forces, and that specific
defects in these structures inhibits their ability to transmit and transduce mechanical forces, causing contractile
dysfunction and pathological cell remodelling. Supporting this, the costamere protein Filamin C (FLNC) has
recently been implicated in a variety of human cardiomyopathies, including DCM. During my F32 postdoctoral
training, I used a new mouse model that exploits cardiac-specific and inducible homozygous FLNC deletion to
trigger rapid DCM development. I found that a loss of FLNC causes significant reductions in the tissue- and cell-
level contractility, as well as significant CM remodeling accompanied by a reduction in cortical cytoskeleton
stiffness. However, whether FLNC mutations in humans with DCM cause similar defects in cortex structure and
mechanics, systolic mechanotransmission, and mechanosensitive gene regulation requires further investigation.
Thus, the goal of my proposed research is to integrate quantitative subcellular-level structural and
biomechanical measurements with quantitative measurements of intracellular stress distributions and
hypertrophic gene expression patterns in response to intra- and extra-cellular mechanical perturbations
using human induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CMs) expressing a patient-
specific FLNC-truncating mutation. To accomplish this, I will: (1) combine X-ray diffraction imaging, atomic
force microscopy, and multiscale computational modeling to test the hypothesis that a loss of FLNC disrupts
‘inside-out’ mechanotransmission of sarcomeric forces by dysregulating myofilament lattice geometry via altered
cortical cytoskeleton mechanics in murine CMs, (2) apply these biophysical methods and hypotheses to a new
human DCM model made from gene-edited hiPSC-CMs expressing a patient-specific FLNC-truncating variant,
and (3) combine FRET-based molecular tension sensor imaging, in-vitro extracellular mechanical loading
techniques, and quantitative transcriptomics to test the hypothesis that truncated FLNC dysregulates ‘outside-
in’ mechanosignaling in hiPSC-CMs and promotes DCM remodeling.

Public health relevance
PROJECT NARRATIVE Dilated cardiomyopathy (DCM) is a common and deadly form of genetic heart disease that is often caused by mutations in proteins that comprise structural networks in the cytoskeleton of heart cells (cardiomyocytes), and current treatment options for patients with DCM only delay its progression without addressing the underlying mechanisms. These mutations likely cause disruptions in the way cardiomyocytes sense and distribute mechanical forces generated from the contractile apparatus in the cell and/or mechanical cues from extracellular stimuli, but the role of these mechanosignaling pathways in DCM progression remains unknown. The research I propose here will employ gene-edited murine and human cardiomyocytes that express DCM-causing defects in the cytoskeletal protein Filamin C, which will be used in computational and experimental approaches designed to reveal how Filamin C regulates subcellular structure, the transmission and distribution of intracellular forces, and mechanically triggered gene expression of hypertrophic biomarkers in the cell, with the long-term goal of discovering novel treatments that can prevent or attenuate mechanically induced pathological remodeling in the heart.